FDACS - PAR-20-105 - Laboratory Flexible Funding Model

Project Summary
Laboratory Flexible Funding Model
(LFFM) (U19) Clinical Trials Not Allowed
PAR-20-105
Florida Department of Agriculture and Consumer Services (FDACS)
Division of Agricultural Environmental Services (AES)
Proposal to FDA for Participation in the Laboratory Flexible Funding Model
(LFFM) (U19) Clinical Trials Not Allowed PAR-20-105
Project Date: September 01, 2020 – August 31, 2025
The Florida Department of Agriculture and Consumer Services (FDACS) is requesting
funding to enhance the capacity and capabilities of Florida's Animal Food testing
laboratory in support of an integrated food safety system through participation in the
Laboratory Flexible Funding Model (LFFM) (U19) Clinical Trials Not Allowed PAR-20-
105 for the disciplines and analytical tracks listed below. Refer to the Overall and
Individual Analytical Track Research Strategies for details.
Discipline Analytical Tracks
B: Chemistry Track 1: Food Defense
Track 3: Animal Food Product Testing
Track 4: Chemistry Capability / Capacity Development
D: Special Projects Track 1: Sample Collection
Track 2: NFSDX Integration or ORAPP Adoption
Track 3: Method Development and Method Validation

Public health relevance
Project Narrative Laboratory Flexible Funding Model (LFFM) (U19) Clinical Trials Not Allowed PAR-20-105 Florida Department of Agriculture and Consumer Services (FDACS) Division of Agricultural Environmental Services (AES) Proposal to FDA for Participation in the Laboratory Flexible Funding Model (LFFM) (U19) Clinical Trials Not Allowed PAR-20-105 The Florida Department of Agriculture and Consumer Services (FDACS) is requesting funding to enhance the capacity and capabilities of Florida's Animal Food testing laboratory in support of an integrated food safety system through participation in the Laboratory Flexible Funding Model (LFFM) (U19) Clinical Trials Not Allowed PAR-20- 105.